Comparative Eukaryotic Genomics

The purpose of this project is to utilize genomic data, primatily those concerned with sequences of complete intergenic regions og genomes, in order to learn more about functions of non-coding eukaryotic DNA. For this purpose, we developed a software tool OWEN for rapid, hierarchical alignment of very long sequences such that similarity between them can be represented by a chain of successive local alignments. Alignments obtained in this way were used for the following studies: - quantitative description of selective constraint revealed by Homo - Mus and Caenorhabditis elegans - C. briggsae alignments, - analysis of domestication of ancient transposons MIR and L2 in mammals, - classification of highly conserved, common fragments in mammalian non-coding DNA,